UAB Pre-Doctoral Training Program in Obesity-Related Research

Project Summary
Obesity is a major source of morbidity and mortality, and especially of heart, lung, and blood–
related morbidity and mortality. This renewal application for a highly successful interdisciplinary
predoctoral training program offers coordinated mentorship, didactic training, career
development activities, and supervised research experiences to prepare PhD students for
careers as independent investigators. The established predoctoral program will build on three
successful funding cycles and complements and interfaces with our existing NIH-funded T32
program for postdoctoral training in obesity research. Students entering their second year of
PhD training enroll in a formal integrated program tailored to individual interests. Trainees
participate in the investigative programs of UAB’s NIH-funded Nutrition Obesity Research
Center, one of only 11 such centers nation-wide. Each trainee has an individual mentoring team
consisting of a primary mentor and two co-mentors with one mentor from each of three major
disciplinary domains (biological/medical; behavioral/social; quantitative/theoretical). The
faculty’s disciplinary diversity (nutritionists, exercise scientists, physicians, psychologists,
statisticians, physiologists, geneticists, epidemiologists, etc.) and strong collaborative ties
facilitate multidisciplinary training. Students from any UAB department may apply to this
program, but trainees must have a mentoring team from this T32 program’s approved faculty. All
students, regardless of their departmental affiliation, participate in all activities and coursework
for this T32 program. Individuals are recruited from the large pool of eligible first-year PhD
students on campus and are selected via formal application and committee review, based on
graduate school performance, faculty recommendations, and consideration of the degree to which
their interests fit with those of the faculty and ongoing research programs. All trainees must plan
to pursue an investigative career in obesity-related research. The program promotes an
approach to investigation that is scientifically and ethically rigorous. Individual trainees’ regular
reviews with the program directors ensure that they make adequate progress toward an
independent research career. We have shown great success in attracting talented trainees and
guiding them toward careers as independent scientists. Our program is currently funded for
eight trainee slots, and we request continued support at this level.

Public health relevance
Project Narrative Obesity is a highly prevalent condition that exacts a high price in suffering for afflicted individuals and economically for society. Causes are complex, manifold, and only partially understood, and available treatments are only modestly effective, impractical, or unrealistically expensive. New scientific insights are badly needed, and training a new generation of multidisciplinary obesity researchers is essential to meet that objective.